Diagnosing the Unknown for Care and Advancing Science (DUCAS)

ABSTRACT
Individuals with rare conditions often experience long diagnostic odysseys, which cause physical and
emotional burdens and delay effective treatment and management. The Undiagnosed Diseases Network
(UDN) has made significant progress in collaborative clinical and research approaches to provide answers to
patients with undiagnosed conditions. However, critical areas require attention, including access to research
approaches and representation from communities experiencing health disparities. As the Data Management
Coordinating Center (DMCC), we aim to address these gaps and enhance the UDN's impact. Our specific aims
are to provide essential research infrastructure, increase outreach to underserved communities, and optimize
research efficiency through technical solutions. By expanding research capabilities, engaging communities
experiencing health disparities, and leveraging advanced technologies, this research will advance the
diagnosis and understanding of rare and undiagnosed conditions, benefiting patients, the scientific community,
and the healthcare system.

Public health relevance
PROJECT NARRATIVE Patients with rare and undiagnosed conditions require a coordinated approach to diagnosis, research, and care. Without proper facilitation and handoffs to advanced diagnostics and research approaches, patients and families experience poor outcomes and pose a burden on our healthcare system. As part of this project, we will improve access to research approaches for undiagnosed patients, enhance representation from communities experiencing health disparities, and optimize the ability to diagnose and understand rare and undiagnosed conditions.